MULTIPLE DOSE STUDY OF TIRAPAZAMIN IN SUBJECTS WITH STG IIIB NSCLC

The primary objective is to assess the efficacy of the combination of radiotherapy plus multiple-dose tirapazamine in subjects with Stage IIIB NSCLC. Endpoints include the degree of local control as measured pathologically, for subjects deemed to have achieved radiographic complete response or partial response at approximately 90 days after the final radiation treatment. The secondary aim will be to assess the radiographic objective response rate and the safety of the combined treatment regimen in the stated population.